Admixture analysis of acute lymphoblastic leukemia in African American children: the ADMIRAL Study

This attachment is not required for the diversity supplement request.

Public health relevance
This attachment is not required for the diversity supplement request.